Prenatal Arsenic Exposure Alters Keratinocyte Stem Cells' Fate and Induces Skin Tumors with Higher Malignant Potential

SUMMARY/ABSTRACT
The goal of this R03 proposal is to establish a scientific basis to understand the effect of transplacental arsenic
exposure on keratinocyte stem cells (KSC) fate and the elevated rate of malignancy of skin tumors. Drinking
water contamination with arsenic is a global problem and a concern in some areas of the United States,
especially in the West and small areas of New England. Inorganic arsenic is considered a human carcinogen
with many target tissues, including the skin. Previous reports have shown that fetal arsenic exposure increases
the multiplicity and aggressiveness of mouse skin tumors. Arsenic has transplacental carcinogenic activity, and
since its fetal abundance, stem cells (SCs) seem to be the main target during gestation. We have established
that fetal arsenic exposure via maternal drinking water leads to decreased KSCs in offspring. Analysis of these
KSCs shows increased levels of proliferative regulators such as cyclin D1 and CDK4. Supporting this
observation, transgenic expression of CDK4 in KSCs mimics arsenic exposure as demonstrated by the reduced
number of KSCs, decreased number of benign skin tumors, and severe rise in the rate of malignancy later in life.
The central hypothesis to be tested is transplacental arsenic exposure alters components of the proliferative
pathway in KSCs, leading to the selection of KSCs with high malignant potential.
Thus, we expect that the work proposed in this proposal will open new research avenues for future studies to
provide new cellular targets for therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Arsenic contamination of drinking water is a global problem and a concern in some areas of the United States since arsenic is a human carcinogen that targets many tissues. We have recently observed that fetal arsenic exposure leads to changes in the number of mouse keratinocyte stem cells (KSCs) of the offspring, an event that mimics the transgenic expression of proliferative cell regulators. The studies proposed in this application will identify the role of in utero arsenic exposure selecting KSCs that give origin to skin tumors with higher malignant potential.